The landscape of NFκB transcription dynamics

Summary/Abstract
The mechanism by which transcription factors assemble active transcription complexes on specific DNA
sequences does not appear to follow a simple recognition code. Direct readout, wherein specific residues in
the transcription factor “read” the specific DNA sequence through direct interactions is most often assumed to
apply due to an oversimplified view of DNA as a rigid molecule. However, subtle, and not-so-subtle, structural
changes occur when DNA binds to transcription factors. In addition, the DNA binding domains of transcription
factors exhibit a large range of flexibility and often contain intrinsically disordered regions. These elements of
flexibility endow the problem of transcription factor-DNA molecular recognition with many of the features of the
protein folding problem. Our overall hypothesis is that transcription factor-DNA binding would instead be better
described by similar principles as have been elucidated for the protein folding problem. Here, we will focus on
the stress-response transcription factor, nuclear factor κB (NFκB), which activates hundreds of genes involved
in growth regulation and the immune response. We will combine rigorous theory with molecular biophysical
experiments to study the assembly kinetics of NFκB transcriptosome complexes. We will investigate coupling
between DNA and NFκB as it relates to tandem κB sites, nucleosomal DNA, and the DNA-binding co-activator,
RPS3. We predict that NFκB and additional nuclear proteins assemble into specific NFκB transcriptosomes on
κB-DNA sites via a cooperative assembly process. We will test this hypothesis with the following aims: Aim 1
Determine the role of DNA context in NFκB binding. We will test the hypothesis that DNA context plays a key
role in determining which NFκB binding events result in transcription activation by studying the binding of NFκB
to a series of bona fide NFκB promoter and enhancer sequences both theoretically and experimentally. Aim 2
Explore how NFκB interacts with nucleosomal DNA and can invade or unwind nucleosomal DNA. We will test
the hypothesis that NFκB is capable of disrupting nucleosome stability in a manner dependent on NFκB
concentration and the sequence of DNA that is wrapped by the nucleosome, thereby exposing DNA for the
initiation of transcription. Atomic force microscopy and computational modeling of the NFκB interaction with
nucleosomes will be pursued. Aim 3 Determine how the ternary interaction between DNA, NFκB and the
transcription co-activator, RPS3 forms. The NFκB coactivator, RPS3, associates with, and activates, subsets of
NFκB transcription activation sites forming higher-order NFκB transcriptosome complexes. We will use the
AWSEM-Suite code to predict the structures of these larger protein complexes and will verify the predicted
long-range contacts between proteins and domains by NMR paramagnetic relaxation, SAXS, and HDX-MS
experiments.

Public health relevance
Transcription factors control the expression of genes, but much remains to be understood about how they work. The stress-response nuclear factor κB (NFκB) transcription factor family regulates cell growth, immune responses, inflammatory viral responses, and apoptotic death and is often mis-regulated in cancer, arthritis, asthma, diabetes, AIDS, and viral infections. This proposal combines rigorous theory with a wide range of biophysical experiments to characterize how active NFκB transcription complexes assemble on DNA and nucleosome arrays focusing on how NFκB selects specific genes to activate under different stress conditions in order to gain a deeper understanding of transcription activation in general.